DNA damage and repair in old and young and in participants in the BLSA

Double strand breaks are very dangerous lesions in DNA and must be repaired to allow cells to complete replication and transcription. Cells with deficiencies in double strand break repair are subject to genomic instability and individuals with these deficiencies are often at elevated risk of cancer. The presence of double strand breaks can be determined by examining cells for the phosphorylated form of a histone protein variant known as H2AX. Phosphorylation of the protein occurs rapidly in the vicinity of a double strand break, and persists until the break is repaired. Consequently phospho-H2AX serves a surrogate marker for breaks. This species can be easily detected by immunofluorescence techniques, and thus can be detected in single cells. We are testing the hypothesis that double strand breaks are present in elevated levels in cells from aged individuals, as compared with younger individuals, by determining the level of phospho-H2AX in blood derived cells from donors in the BLSA program. The results indicate that cells from older individuals contain more frequent H2AX sites than cells from younger individuals. We have currently enrolled 45 participants in this study and are seeking to gain additional younger patients <59 and older patients >79 yr old to increase the statistical power of the study.